Pathogenesis, Transmission and Detection of Zoonotic Prion Diseases

ABSTRACT
Prion diseases are a group of infectious neurodegenerative disorders affecting humans and other
mammals, which are transmitted by an unconventional proteinaceous infectious agent termed prion. CWD
is so far the only prion disease of wild animals; it is highly contagious and the exact origin, prevalence, and
mechanisms of transmission remain incompletely understood. The progressive increase of CWD prevalence in
the USA has likely resulted in a substantial contamination of the environment with infectious prions and may
lead to new prion diseases in animals that share the habitat of cervids. The disease has been rapidly
expanding geographically and now affects 27 states in USA, three Canadian provinces, South Korea and
Northern Europe, including Norway, Sweden and Finland. The risk of transmission of CWD to other animal
species or to humans is unknown and surveillance methods to detect the infection in non-cervid species are
limited.
This Program Project has received continuous funding for the past 11 years, which has enabled us to
implement a large and complementary set of unique techniques, model systems, reagents, personnel and
expertise crucial to understand the CWD problem. In the last competitive review, we received a perfect
score of 10 and reviewers identified many strengths and “not any significant weakness”. The progress
during this cycle has been stellar, with many important discoveries and 118 high profile publications. The
main goal of this iteration of the Program Project will be to study the molecular and cellular mechanisms
responsible for prion replication and prion strain diversity in CWD. We will study the generation, mutation and
evolution of CWD prion strains, the inter-species transmission potential of CWD (with particular focus on its
zoonotic potential) and the role of the environment on CWD transmission. This Program Project aims to
address some of the most important questions in CWD research, including the possibly origin of CWD, the
mechanism and routes of transmission of the disease among animals, the natural strain diversity of CWD, the
atomic resolution structure of infectious prions, the evaluation of the zoonotic potential of CWD, the factors
controlling the cervid/human species barrier, the role of the environment on prion transmission and the
development of efficient procedures to detect infectious CWD prions. To achieve these goals, this Program
Project assembles a group of highly accomplished scientists in the prion field, particularly experts on CWD
transmission, who have access to the relevant models, techniques, samples, resources and expertise to
provide a complementary and comprehensive investigation of the problem.

Public health relevance
NARRATIVE This is a competing renewal application of a very successful Program Project Grant that has received continued funding for the past 11 years. During this time we have maintained a strong productivity, we have built a very collaborative and synergistic team and we have implemented substantial expertise and resources to study Chronic Wasting Disease (CWD), a prion disorder that continue to spread uncontrollably among cervids in USA. In this project, we will investigate the mechanism of CWD prion replication and the generation, adaptation and evolution of prion strains, the atomic resolution structure of infectious prions, the routes of transmission of the disease among animals, the evaluation of the zoonotic potential of CWD, the role of the environment on prion transmission and the development of efficient procedures to detect the infectious agent.